Identifying salient factors that influence physician practices in mitigating patient misinformation

Project Summary/Abstract
Medical misinformation is a global health problem with 73% of US adults having been exposed to false health
information and 87% expressing concern about it. Health misinformation can hijack a patient’s typical
discernment faculties and can lead to poor health outcomes. Evidence shows that elderly patients are
disproportionately affected by health misinformation and are more likely to believe and spread misinformation,
and suffer negative consequences. Engaging physicians has been touted as a promising and plausible means
to mitigate misinformation because they are highly trusted, routinely provide reliable medical information, and
are effective at influencing sustainable behavior change. Yet there is virtually no empirical data about physician
misinformation corrective practices. Physician practices to correct patient misinformation is likely to depend on
their political and religious beliefs as seen in other health areas, familiarity with the topic, correction and
communication skills, self-efficacy, and environmental (e.g., time) and interpersonal factors (e.g., exhaustion).
Prior to developing scalable and evidence-based physician communication interventions, a rich assessment of
factors that facilitate or impede physician corrective practices is needed. We use a mixed-methods approach to
identify factors and the strength of association among barriers/facilitators and physician willingness to correct
misinformation through three specific aims using two divergent cases: unproven stem cell therapies and Covid-
19 vaccination. In Aim 1, we will interview primary care physicians to assess knowledge, experience, attitudes,
and beliefs about correcting misinformation. In Aim 2, we will create a novel Determinants of Willingness to
Correct Misinformation (DWCM) measure based on Aim 1 qualitative data, expert review, cognitive interviews,
and psychometrically evaluate dimensionality and internal consistency. A national survey of physicians using
the validated DWCM instrument will be conducted to measure determinants that impact physician corrective
practices and attitudes towards adopting a priori correction strategies in their practice. In Aim 3, we will conduct
online asynchronous focus groups with elderly patients across the US to assess receptivity towards corrective
information from physicians, communication comprehension, channel preferences, and affect towards
receiving corrective information and the use of specific terminology. Upon completing this research, we will
have (i) identified major factors and their association with physician misinformation corrective practices and
their attitudes towards adopting corrective strategies; (ii) created a valid DWCM climate instrument that can be
deployed in different health care environments; (iii) offered data into patient receptivity towards receiving
corrective information from physicians, including modes of exchange and appropriate language, and (iv) be
well-positioned to develop and test the efficacy of a misinformation correction toolkit for physicians in future
research.

Public health relevance
Project Narrative Medical misinformation is a global health threat leading to devastating downstream consequences and while several medical authorities have proposed that physicians should counter patient health misinformation during a clinical encounter, no study has yet comprehensively assessed physician misinformation corrective practices and the factors that facilitate or impede correction. We use two divergent areas for which misinformation is frequently promulgated – unproven stem cell therapies and Covid-19 vaccination – (1) to evaluate physician practices correcting patient misinformation and attitudes towards adopting a priori correction strategies using individual interviews, (2) to develop and validate a new Determinants of Willingness to Correct Misinformation measure to survey a national sample of physicians, and (3) to evaluate elderly patient receptivity towards corrective information from physicians, communication comprehension, channel preferences, and affect towards receiving corrective information using online asynchronous focus groups. These studies will position our group to develop, test, and implement a misinformation correction toolkit for physicians in future research.